GENETIC MODIFIERS OF DUCHENNE MUSCULAR DYSTROPHY

Core A. Administrative. The Administrative Core will integrate scientific and administrative functions of the proposed Wellstone Center. The Administrative Core will be the mechanism by which the Director and Co-Director ensure the highly interactive research of Center investigators. [ Duties of the Core include: [unreadable] Fiscal management of all Projects and Cores; [unreadable] Oversight of utilization of Cores; [unreadable] Convening of oversight committees (Steering Committee, Scientific Advisory Board); [unreadable] Acting upon directives and suggestions of the oversight committees; [unreadable] Representation of the Center in the Consortium. The administrative core will also take responsibility for the ongoing muscle seminar series'(over 100 invited speakers over the last 4 years). This seminar series could be simulcast to other Wellstone Centers. ] The Administrative Core will be sensitive to the needs of all Center investigators, and will also oversee the utilization of the Research Resource Cores (Cores B [Human Clinical Core], and Core C [Computing and Bioinformatics Core] for external investigators, including assessment of performance of the Scientific Research Resource Cores and their cost-effectiveness.